Fast Functional MRI R01 - Administrative Supplement

Project Summary: Administrative Supplment ? Fast Functional MRI with Sparse Sampling and Model- Based Reconstruction This application is being submitted in response to NOT-EB-18-019, as an administrative supplement to facilitate dissemination of technology developed in the parent grant, 5 R01 EB023618, Fast Functional MRI with Sparse Sampling and Model-Based Reconstruction. The overarching goal of the parent grant is to develop a novel ultrafast whole-brain fMRI acquisition approach that expands the spatiotemporal resolution envelope by roughly 3-fold in comparison to the current leading methods. To distribute this new fMRI acquisition to other research sites, we propose to further develop a novel framework for vendor-independent pulse programming developed by our group in collaboration with University Medical Center Freiburg, Germany, and the group of Sairam Geethanath (co-I). Our framework allows the sequence to be designed in, e.g., Matlab and exported via a vendor-independent file format to the MR scanner for direct execution. In preliminary work, we demonstrated that an identical sequence can be played out on both GE and Siemens scanners without the need for the operator to manually specify any aspect of the sequence. This guarantees identicalexecution of all RF and gradient waveforms on both vendor platforms, and eliminates time-consuming and error-prone vendor-specific pulse programming. We therefore believe this framework is ideal for quickly disseminating new MR acquisitions and specifically, those proposed in the parent R01. A major applications domain focus of the parent R01 is to improve low- and high-frequency resting- state functional connectivity measures using the proposed high-speed imaging methods. The proposed supplement project will also validate the reproducibility (test-retest reliability) of resting-state maps across sites and vendors.

Public health relevance
Public Health Relevance: Functional magnetic resonance imaging (fMRI) is used to measure brain function, and has revolutionized our understanding of cognitive processes during the last 20 years and has also been used as a tool for presurgical mapping of language and other sensitive brain regions. More recently, fMRI is being used as a biomarker for the progression of neurologic and psychiatric diseases, for example, in Alzheimer's disease and multiple sclerosis. In this supplement, we will develop tools allow new methods for fast fMRI techniques to be easily shared across equipment vendors to make findings more reproducible across sites.